Aging, Sex Bias, and CD8 T Cell Exhaustion in Salivary Gland Inflammation

PROJECT SUMMARY
Sjögren’s Disease (SjD) is a systemic autoimmune disorder most frequently targeting exocrine glands and
causing oral and ocular dryness. SjD is characterized by serum antibodies to nuclear and cytoplasmic
antigens and salivary gland inflammation (sialoadenitis), which is associated with an increased risk of
lymphoma. For unknown reasons, SjD disproportionately affects females and is typically diagnosed in the 5th-
6th decade of life. Thus, female sex and aging are intricately linked with immune dysfunction and autoimmunity
in SjD. The long-term goal of this project is to understand the age- and sex-related immune mechanisms
involved in the salivary gland pathology of SjD. The proposed studies will utilize male and female mice that
spontaneously develop the salient characteristics of SjD and mimic the age- and sex-bias of the disease.
While both males and females develop systemic autoimmunity, only the females progress to severe
sialoadenitis. We will use a conceptually innovative approach by investigating the immunoregulatory
mechanisms that protect males from severe sialoadenitis. Aim 1 will investigate whether the aged male
salivary gland microenvironment harbors immunosuppressive signals that inhibit progressive inflammation.
We will characterize gene expression changes in immune, epithelial, and stromal compartments using single-
cell transcriptomic profiling of male and female salivary glands at key aging milestones. Recent literature
suggests a prominent role for CD8 T cells in the glandular pathology of SjD. Aim 2 will examine the
differentiation trajectory of CD8 T cells targeting salivary gland antigens in male and female mice. We will
leverage a novel mouse model expressing ovalbumin as a surrogate self-antigen in the salivary glands to
track antigen-specific CD8 T cell activation. Our findings will inform the development of innovative therapeutic
strategies aimed at local immune modulation to alleviate salivary gland pathology in SjD.

Public health relevance
PROJECT NARRATIVE Sjögren’s disease is a chronic autoimmune condition associated with severe inflammation of the salivary glands that can progress to lymphoma, leading to fatal consequences. For reasons currently not understood, the disease disproportionately affects women. This proposal aims to investigate the underlying immune mechanisms responsible for the sex bias in Sjögren’s disease.